The Opioid Crisis: The Effects and Unintended Consequences of State Policies on Opioid Analgesic Prescribing

Project Summary
The U.S. is facing an opioid-related public health crisis, and states have responded with a range of policies and
initiatives, many of which are intended to decrease the widespread availability of opioid analgesics. Our
understanding of the impact of these policies is still evolving, results of studies have been mixed, and no
studies have examined to what extent policies have decreased potentially inappropriate prescribing while
leaving likely appropriate prescribing untouched. To assess the impact of state policies and initiatives on
overall opioid prescribing rates, likely appropriate prescribing, and potentially inappropriate prescribing, this
project will produce empirical findings addressing these gaps using Medicare claims data for disabled
beneficiaries, as well as IQVIA data which covers an estimated 88% of prescriptions filled at U.S. pharmacies.
It will also examine how policies affect opioid prescription fills for historically underserved and high-risk
populations. The results will inform state policymaking efforts related to the opioid crisis.

Public health relevance
Project Narrative This project will assess the impact of state policies designed to decrease the availability of opioid analgesics and to what extent policies decrease potentially inappropriate prescribing while leaving likely appropriate prescribing untouched. We will also examine the effect of state policies on opioid prescription fills by historically underserved and high-risk populations.